Task B11: Sample Storage to Support a Label Change for Amoxicillin and Amoxicillin-Clavulanate

This contract provides for the development of new and refinement of non-human primate models of infectious diseases and may include evaluation of candidate countermeasures.